SERUM AND CSF DRUG LEVELS AND D2 OCCUPANCY FOR PALIPERIDONE AND RISPERIDONE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. This project has been completed. Our paper describing our method of chronic intragastric infusion has been published. Our findings on the dopamine receptor binding of these drugs have been submitted for publication and a revised manuscript is being prepared.